Efficacy of External Trigeminal Nerve Stimulation for Treatment of ADHD

Project Summary/Abstract
High prevalence rates of attention-deficit/ hyperactivity disorder (ADHD) (5-11% of children 4-17 years),
combined with its high societal cost, strong persistence and pernicious effects on quality of life, warrant continued
efforts to understand its underlying neural mechanisms and find efficacious treatments. Clinical heterogeneity is
a major challenge, likely related to multiple causal paths, and contributes to variability in clinical presentation,
underlying neural mechanisms, and treatment response. Although psychostimulants are the gold standard of
treatment for ADHD, problems with suboptimal response, adverse side effects and non-compliance occur for a
significant minority of those with ADHD. As a result, there is a critical need for empirically supported non-
pharmacological interventions for ADHD. In addition, a reliable method for predicting response to treatment
interventions in ADHD (and psychiatry in general), both medication and non-pharmacological approaches alike,
remains elusive. This inability to prospectively predict whether a treatment approach will be effective for a given
individual is costly and time consuming for professionals and patients, and often inconclusive due to
disagreement between informants. In this project, we will conduct a large, multisite randomized clinical trial to
test the efficacy of external trigeminal nerve stimulation (TNS), a novel, minimal risk, non-invasive
neuromodulation treatment, for ADHD in children ages 7-12 years old (N=180). This high impact project will
contribute significantly to the literature for empirically-supported nonpharmacological interventions for ADHD,
identify underlying neural mechanisms, and test clinically useful behavioral and cognitive predictors of treatment
response. Confirming the efficacy of TNS for ADHD could provide millions of families a viable non-
pharmacological treatment option, and in some cases, as first-line treatment strategy for patients with ADHD, if
supported by this research. The validation of a behavioral profile that is significantly predictive of treatment
response will make identification of patients appropriate for TNS treatment simple and extremely cost effective
as well as enhance dissemination of treatment into the community. This proposal is consistent with several NIMH
priorities, including the development of innovative interventions, assessment of the mechanisms of action of
efficacious interventions in the brain and identification of behavioral and cognitive characteristics to guide
treatment approaches.

Public health relevance
Narrative To address the critical need for empirically supported non-pharmacological interventions for attention-deficit/ hyperactivity disorder (ADHD), we will test Trigeminal Nerve Stimulation (TNS), a novel, minimal risk, non- invasive neuromodulation treatment, within a large independent sample of children aged 7-12 years old at two independent research sites (UCLA, Seattle Children’s Research Institute). In addition, we will test the underlying neural mechanism of TNS treatment as a mediator of ADHD symptom change. Finally, we will identify baseline behavioral and cognitive predictors of positive treatment response to TNS in order to inform a personalized treatment approach.